SMALL ANIMAL IMAGING FACILITY

PROJECT SUMMARY (See instructions): The Small Animal Imaging Facility (SAIF) provides Cancer Center Members with powerful imaging technologies, staff and expertise necessary to integrate imaging into preclinical cancer research. The facility is led by Drs. John D. Hazle and James A. Bankson and is supported by a network of faculty with research expertise in each imaging modality. Faculty and staff consult with users prior to planning of imaging experiments, and assist in all aspects of imaging services, including preparation of grants, experimental design, protocol optimization, data acquisition and analysis, interpretation, presentation, and publication of results. Instrumentation and full-service support are available for preclinical MRI (4.7T/40cm, 7.0T/30cm) including hyperpolarized

Public health relevance
RELEVANCE (See instructions): The Small Animal Imaging Facility provides access to imaging instrumentation and expertise that allows Cancer Center Members to integrate powerful and cutting-edge imaging technologies into routine preclinical research with confidence that their scientific objectives will be achieved. The SAIF has also developed a new multi-animal imaging platform to reduce the cost of imaging in small animal research.